Prospective Genetic Risk Evaluation and Assessment (PROGRESS) in Autism

PROJECT SUMMARY
The Prospective Genetic Risk Evaluation and Assessment (PROGRESS) in Autism Center at Columbia
University will accelerate multidisciplinary research in a diverse population-based newborn cohort focused on
early life identification of genomic risk variants for autism, parent experience with receiving this genetic
information, and the analysis of early neurobehavioral trajectories to predict autism. Newborn screening using
genomic sequencing is a platform that can deliver genetic diagnoses before autism symptoms emerge –
providing the opportunity for early intervention but also raising numerous questions about family impact and
appropriate management of the child. Although early intervention improves autism outcomes, there currently are
no established neurobehavioral markers to predict autism in genetically at-risk infants. With its unifying theme of
Advancing Early Evaluation of Genetic Risk in Autism: Foundations, Implications, and Potential, the
PROGRESS Center will harness expertise in genomics, developmental neuroscience, autism diagnosis,
psychosocial assessment, and data science to address these gaps in autism research. We will leverage a funded
project piloting whole genome sequencing in a diverse population-based group of 100,000 infants in New York
City, allowing us to identify rare, monogenic (e.g., CHD8) conditions associated with high risk for autism to
prospectively enroll and longitudinally follow 240 infants at identified genetic risk (IGR) of autism (out of ~400
eligible) and a matched group of 120 infants without identified genetic risk (non-IGR) of autism (together
comprising the PROGRESS cohort). Because experiences and attitudes likely vary across race, ethnicity, and
socioeconomic status, our diverse, population-based cohort will maximize generalizability of our findings. The
three proposed Center Research Projects are built around this cohort. Project 1 will identify genes and genetic
variants to improve autism risk prediction by using large existing genomic datasets and prospectively evaluate
genomic risk prediction in the PROGRESS cohort. Project 2 will examine the immediate and longer-term impact
of receiving genetic information on psychosocial function and parental self-efficacy in parents of PROGRESS
cohort infants. Project 3 will identify emerging neurobehavioral trajectories and assess the utility of these
trajectories in improving the prediction of later autism diagnosis among IGR infants. These inter-related Projects
will be supported by four Cores that also will be a resource of excellence to local, national, and global autism
researchers for innovative analytic strategies; rigorous diagnostic methods; support for and engagement of
autism communities in research; and capacity building for new autism researchers.

Public health relevance
PROJECT NARRATIVE The Prospective Genetic Risk Evaluation and Assessment (PROGRESS) in Autism Center at Columbia University will identify and study a diverse, population-based cohort of infants with monogenic risk for autism to evaluate the impact of early life identification of genomic risk variants on parent experience, neurodevelopmental trajectories, and prediction of autism diagnosis.